Translational Vaccinology for Global Health

ABSTRACT Support is requested for a Keystone Symposia meeting entitled Translational Vaccinology for Global Health, organized by Drs. Christopher L. Karp, Gagandeep Kang and Rino Rappuoli. The meeting will be held in London, UK from October 26-30, 2016. The time required to launch new global health vaccines is too long and the late failure rate is unsustainably high. Key barriers include insufficient diversity and quality of preclinical concepts and candidates, immunobiological ignorance, and a lack of understanding of correlates or mechanisms of protection. Root causes include siloed science and linear thinking; poor integration across the discovery/development/delivery ecosystem; and slow entry and limited throughput in early human proof of concept testing. This meeting aims to bring together those pioneering novel, creative solutions to these problems of global vaccine discovery and development across the academic/biotech/product development partner/pharma spectrum.

Public health relevance
PROJECT NARRATIVE Vaccines represent one of the most cost-effective approaches to addressing global health inequity, but the time required to launch new global health vaccines is too long and the late failure rate is unsustainably high. The Keystone Symposia meeting on Translational Vaccinology for Global Health will bring together a diverse group of basic and applied scientists working in microbial pathogenesis, immunology and vaccinology to highlight novel approaches to vaccine discovery and development. By bringing together researchers from across the spectrum of expertise on these issues, we hope to make a significant contribution to advancing the field and its potential to advance human health around the world.